Novel high-field MRI compatible subdural electrode and acquisition system for recording and stimulation in small animals

Abstract
Preclinical small animal imaging makes valuable contributions to improving
our understanding of human brain. Multi-modal imaging approaches to combine
functional Magnetic Resonance Imaging (fMRI) with Intracranial
Electroencephalogram (iEEG) provides an unparalleled view of the global network
activity across cortical areas, revealing information at high temporal and spatial
scales about functional connectivity and their intrinsic oscillatory properties, which
is of vital importance in many branches of neuroscience and medicine. Despite this
clear advantage, the use of iEEG-fMRI is limited in small animal research. The
existing MRI compatible headstages on the market for small animals are
inadequate to acquire high-fidelity iEEG-fMRI. Working within this premise, the
long-term goal of this project is to develop a headstage for high-fidelity recording
and stimulation in small animals. We propose to unlock high-fidelity iEEG-fMRI
imaging paradigm leveraging our patented innovative MRI-compatible electrode-
grid (PTFOS) which is based on organic-absorbable, stretchable, and conformable
substrate for optimal safety, flexibility and performance with distinct advantages
over other neural grids. Phase I of this application proposes to develop HF-2
acquisition prototype which will fit into animal MRI bore recording constraints and
tests its feasibility in rats during high-field MRI (9.4Tesla) at Massachusetts
General Hospital. Phase II focuses on adding stimulation module,
commercialization and miniaturization of HF-2 into a tiny headstage.

Public health relevance
Narrative: Preclinical small animal imaging makes valuable contributions to improving our understanding of human brain. This application proposes a patented imaging tool to unlock multi-modal imaging approaches in small animal that provides an unparalleled view of the global network activity across cortical areas.